Project 4 - Mechanisms of establishing clonal dominance

ABSTRACT
Hematopoietic clonal imbalance predisposes individuals to hematopoietic disorders, some progressing to
myelodysplasia. During aging, mutations arise that lead to clonal dominance. In transplantation or gene therapy
trials, clonal alterations complicate therapy. Somatic genetic mutation(s) may bestow a selective growth
advantage to a single hematopoietic stem cell so that it will eventually outgrow normal (wild type, WT) cells
causing clonal imbalance. Early detection of such cells is key to therapeutically intervene to block progression
to a blood disorder. The Zebrabow zebrafish allows color barcoding and tracking of individual hematopoietic
stem cells during differentiation into peripheral blood cells in vivo. A recently developed technique called TWISTR
allows mosaic targeting of genes in the Zebrabow genetic background. Without the need for transplantation, a
robust competition assay between WT and single gene mutant hematopoietic stem cells can be monitored using
the color-based cellular barcoding TWISTR system. The dominant clone can be sorted via flow cytometry and
compared to non-dominant clones for downstream analysis. Mosaic mutagenesis of ASXL1 leads to clonal
dominance, and we found that inhibition of the NR4A1 anti-inflammatory pathway using CRISPR or chemical
inhibition restores clonal balance. Using metabolomics, we have found that choline metabolism is altered in
dominant asxl1 mutant clones. In Aim 1, pharmacologic experiments will be performed to evaluate the NR4A1
pathway in facilitating clonal dominance and genetic experiments targeting choline-related metabolic genes will
identify metabolic targets for suppressing clonal dominance. We also found that macrophages play a role in stem
cell clonality through physical interactions with hematopoietic stem cells. Macrophages interact with the “eat me”
signal, Calreticulin, on the surface of hematopoietic stem cells to determine their fate. In Aim 2, we plan to
evaluate mutants of Calreticulin orthologs and examine the effects on clonality. We plan to probe the mechanism
of the induced clone expansion after macrophage interactions. We also have undertaken a chemical genetic
screen to find inducers of Calreticulin on the surface of zebrafish and human hematopoietic stem and progenitor
cells and will study specific compounds that can induce an “eat-me” signal for dominant clones. Our studies will
have an impact on the basic understanding of clonal balance and will lead to potential therapies for clonal
dominance.